COMPARISON OF FULL TRYPTIC, SEMI-TRYPTIC, AND NON-TRYPTIC SEARCH STRATEGIES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We are interested in determining if the extra computational overhead is worth the increase in peptide and protein identifications to do searches without trypsin specificity.